Decision Neuroscience of Craving

Project Summary/Abstract
The current opioid epidemic is a pressing public health crisis. A key precipitating factor of reuse and relapse
among people with opioid use disorders (OUD) is craving, or the intense, specific desire for the drug. While
craving has been extensively studied, and is known to predict drug use, we still lack an explanatory and
algorithmically-precise model that can directly link craving neurobiology to its observed consequences: the
decision to pursue drugs over other valuable alternatives. Given that typical treatments for OUD do not
adequately address craving and fail to prevent reuse in many patients, clarifying the precise, decision-relevant,
mechanism of craving may critically inform more targeted ways to treat craving and improve clinical outcome.
To address these important questions, we developed an experimental paradigm to study craving based on
methods widely used in decision neuroscience to assess value-based decision-making. Decision neuroscience
(or neuroeconomics) integrates concepts and methods from psychology, economics, and neuroscience to
understand the neural architecture for decision-making, and has been increasingly applied in mechanistic
studies of psychiatric disorders including addiction. Our paradigm constitutes a novel application of this
framework by quantifying a subject’s in-the-moment (i.e., state-dependent) decision process during craving15.
In pilot behavioral studies in healthy and opioid addicted subjects, we find that this paradigm captures 1) how
value—the key determinant of the decision to pursue a particular option versus another—changes under
craving, and 2) the selectivity of this effect to the object of craving. It also 3) provides an algorithmically-specific
process (a mathematical description) of this change that can be used to tie behavior to its neural substrate. In
the present study we aim to elucidate this neural substrate by identifying the specific neural computations
through which craving modulates the value of drug and nondrug alternatives and thereby drug use decisions in
human OUD. We propose to identify the neural substrate of opioid craving in N=89 OUD patients who will
complete our paradigm during fMRI in a within-subjects cross-over design following a brief craving induction or
a control manipulation16. Because decision circuits encode value in a reward-identity specific manner, our
design will enable us to isolate the computations associated with drug-related value from those of nondrug
value. Our study will for the first time determine whether and how experimentally-induced craving dynamically
shifts such “identity-specific” neural encoding of drug-related value (Aim 1), and the parts of a putative ‘craving
circuit’ involved in this shift (Aim 2). To test whether this mechanism is unique and reward-identity specific, we
will also measure brain activity associated with experimentally-induced food craving and specific food-value in
the same patients and N=89 healthy controls (Aim 3). If successful, this integrative approach will uncover
precise targets for selectively mitigating craving-induced increases in drug-value that promote opioid reuse,
laying the groundwork for precision interventions to treat craving in treatment unresponsive individuals.

Public health relevance
Project Narrative Craving is one of the most clinically-important symptoms experienced by individuals in treatment, including those with opioid use disorders for whom several evidence-based treatments exist. Unfortunately, these treatments do not adequately address craving and reuse and relapse are the modal outcomes. If successful, this study will have uncovered a previously unknown biological indicator of how craving works to bias decisions toward drug use in addicted individuals. Studies can then use this indicator as a target of treatment, perhaps ultimately culminating in the implementation of interventions to reverse the specific decision biases induced by craving and thus improve patient outcomes.